Cervical Cancer Prevention Prebiotic Device

In this Phase II SBIR project, Glyciome, a women-owned company, is commercializing ‘PreBioGyn’, a prebiotic
intravaginal lubricant designed to prevent bacterial vaginosis (BV), the most common vaginal infection in the
world and an established biological risk factor for cervical cancer (CC). There is an urgent need to prevent this
cancer (the 4th most common for women globally), which is causing rising death rates in the US for those in low-
resource settings (LRS). Our patent-pending, preservative-free therapeutic device offers a disruptive
microecological approach to CC prevention for use by anyone - regardless of their human papillomavirus (HPV)
vaccination status - to optimize women’s health and reduce public health costs. This is critical in the US, where
<60% of teens and fewer adults are fully vaccinated against HPV. About 1 in 4 female Americans (e.g., 34 million
people) have BV, resulting in disease-related public health costs of $10B/yr. Current BV treatments include
antibiotics and vaginal lubricants (for symptom management), resulting in ~40% disease recurrence rates, with
increased HPV infection and CC risks due to iatrogenic vaginal cell and beneficial vaginal microbiome toxicity.
PreBioGyn is a preservative-free, therapeutic device that will have first-in-class claims as a pre-coital lubricant
to support vaginal ecosystem health for use across reproductive life stages, including subsequent development
as the first-ever lubricant in the US cleared for use during pregnancy. The latter is urgently needed, given that
half of BV and CC patients are reproductive-aged women. The beachhead market for PreBioGyn’s approach to
BV and CC prevention, as a lubricant to optimize vaginal health, will offer benefits to anyone, including those
who have received the HPV vaccine, those already infected with HPV, and those who refuse vaccines. The
Phase I studies of PreBioGyn provided a solid foundation for this Phase II SBIR with in vitro product proof-of-
concept established for vaginal cell and vaginal microbiome safety as compared to existing BV-relief lubricants
(with the US current market leader having $60MM/yr. in sales). Phase II Aims will support sequential regulatory
clearances for PreBioGyn for use across reproductive stages with an initial product launch within two years,
including the completion of the following tasks:
Specific Aim 1 Finalize manufacturing of PreBioGyn in commercial enclosures for Phase II Aims and launch.
Specific Aim 2 Complete biocompatibility assays for FDA clearance for PreBioGyn as a gamete-safe lubricant
for fertility patients and design the pathway for subsequent product clearance for use during pregnancy.
Specific Aim 3 Conduct a safety and feasibility randomized clinical trial (RCT) of PreBioGyn in at least 70 LRS
subjects recently treated for BV. Commercial Application. The PreBioGyn market will intersect with two US
retail categories: personal lubricants (US sales $325MM/yr., global sales $2B/yr.) and feminine symptom
treatments (US sales $350MM/yr). PreBioGyn sales of $75MM/yr. will provide near-term CC prevention across
local healthcare systems and grow Glyciome’s presence in the $127B/yr personal care industry.

Public health relevance
NARRATIVE In this Phase II SBIR project, Glyciome, a women-owned company, is commercializing ‘PreBioGyn’ a prebiotic intravaginal lubricant designed to prevent bacterial vaginosis (BV), the most prevalent vaginal infection in the world and a recognized biological risk factor for cervical cancer. Our patent-pending, preservative-free therapeutic device offers a disruptive microecological approach to preventing this cancer, which disproportionately harms those in low resource settings in the US and globally. PreBioGyn will be an affordable, first-in-class cervical cancer and BV prevention strategy for use by anyone - regardless of their human papillomavirus vaccination status - to optimize women’s health and reduce Public Health costs.